Enhancing Genome-Wide Association Studies via Integrative Network Analysis

DESCRIPTION (provided by applicant): Many common diseases arise from complex interactions among multiple genetic and environmental factors. Genome Wide Association Studies (GWAS) comprehensively compare common genetic variants in affected and control populations to identify variants that are potentially associated with disease. In recent years, GWAS successfully identified susceptible genes for many diseases. However, researchers recognize many limitations of GWAS in characterizing the genetic bases of complex diseases, including reduced statistical power due to small sample size, inadequacy of separate consideration of individual variants in capturing the interplay between multiple factors, modest success in predicting individual risk for disease, and lack of insights into the biological and functional mechanisms that relate identified variants to the disease. This project aims to enhance GWAS by using protein-protein interaction (PPI) networks as an integrative framework to interpret the outcome of GWAS within a functional context. PPI networks characterize the physical and functional interactions among functional proteins; thus they are useful in understanding the functional relationships between multiple genetic factors. This project will facilitate effective use of PPI networks to identify the functional relationships among genetic factors implicated in GWAS by developing efficient computational algorithms that will integrate multiple sources of omic data. In particular, to enhance the relatively weak association signals captured by GWAS, we will combine association scores of individual proteins to identify interacting groups of proteins that exhibit a stronger association signal when considered together. We will also search for combinations of multiple genetic factors that are associated with disease by confining the search space to known physical and functional interactions. We will also score identified groups of proteins in terms of their collective differential expression in the disease, with a view to gaining insights into the relationship between genetic differences and dysregulation of gene expression. We will extensively test the proposed algorithms on a variety of diseases, using large case-control datasets obtained from public databases (Wellcome Trust Case-Control Consortium and The database of Genotypes and Phenotypes), as well as our collaborators. In particular, we will extend our existing collaborations with the Candidate Gene Association Resource (CARe) project that includes 40,000 individuals and validate our algorithm development through functional gene association with cardiovascular phenotypes of importance in the CARe project. This research will result in novel computational tools that will reliably connect genomic data to function and disease phenotypes to drive focused and effective mechanistic studies of complex diseases (including clinical studies and studies in model organisms) by our collaborators and the wider biomedical science community, ultimately providing diagnostic and prognostic biomarkers and mechanistic insight to inform clinical studies more comprehensively and effectively than existing GWAS.

Public health relevance
Project Narrative Genome-wide association studies (GWAS) aim to uncover the genetic bases of diseases by comprehensively screening the human genome to discover genetic variants that are associated with the disease. This project aims to enhance these studies by developing computational algorithms that will facilitate interpretation of such genetic variants in the context of their biological function and relationship to each other. These algorithms will be tested on a wide variety of diseases and also applied obstructive sleep apnea and related diseases to shed light into the complex relationships between genetic factors that contribute to these diseases. __SpecificAimsTextDelimiter__ 2. Specific Aims The purpose of this application (in response to RFA-!PAR-11-208) is to develop and use computational models and algorithms that integrate genomic, transcriptomic, and interactomic data to increase the impact and effectiveness of genome-wide association studies (GWAS). This research will result in novel computational tools disseminated to the research community that will reliably connect genomic data to function and disease phenotypes to drive focused and effective mechanistic studies of complex diseases, provide diagnostic and prognostic biomarkers to inform clinical studies, and identify potential drug targets. Recent research suggests that systems biology approaches that integrate multiple sources of -omic data are effective in functional biomarker and target discovery for characterizing complex diseases. While the use of well-characterized pathways and functional annotations have been useful in this regard, protein-protein interaction (PPI) networks obtained via high-throughput screening offer a complementary platform that will help discover novel functional links. Motivated by these considerations, the proposed research aims to develop and validate novel computational models and algorithms that will use PPI networks as an integrative framework to integrate and mine correlations between disparate sources of -omic data to empower GWAS. In particular, the proposed methods will adapt concepts and results from information theory to functionally interpret the outcome of single-locus based association studies (Aim 1), and identify combinations of multiple loci that are functionally related through protein subnetworks (Aim 2). These methods will be validated in the context of several diseases including type 2 diabetes, breast cancer, Parkinson's disease, schizophrenia, and sleep apnea, using data obtained from public resources, as well as collaborators of the project team (Aim 3). Aim 1: Development of computational algorithms to identify sub-networks enriched in proteins that harbor disease-associated genetic variants. An important fraction of GWAS focus on single-locus based associations, i.e., genetic variants (for example, SNPs) that individually exhibit modest statistical power in describing affected populations. Due to the complexity of the underlying mechanisms of many genetic diseases, as well as limitations posed by sample size, GWAS often return a large number of variants with moderate significance of association. Interpretation of these apparently "weak" associations in the context of PPI networks may uncover important functional relations among these variants, offering mechanistic explanations for their functional relevance to disease. We will develop a suite of computational algorithms to identify "disease-gene enriched subnetworks", i.e., PPI subnetworks that exhibit significant network connectivity (hence, functional relationship) to products of potentially disease-associated genes. Aim 2: Development of computational algorithms to identify protein subnetworks corresponding to combinations of genetic variants that together describe patient sub-populations. As single-locus based associations are limited in defining the genetic bases of complex diseases, combinations of loci that exhibit enhanced statistical power over individual loci are proposed for analyzing the relevant populations. However, identification of such "epistatic" interactions is generally limited to pairs of loci. To render the search for multiple interacting loci feasible, we will confine the search space to known physical and functional interactions represented in PPI networks. For this purpose, we will develop algorithms to identify interacting proteins whose coding/regulatory regions harbor combinations of genetic variants that (i) can describe the variance in a subset of the patient population ("population clustering sub-networks") and (ii) complement each other in describing the variance in the entire patient population ("population covering sub-networks"). Aim 3: Validation of proposed algorithms through identification of novel genetic markers and risk assessment in various diseases. Our hypothesis is that individual variants, that are not statistically significant when considered in isolation, may be associated in PPI networks and that their significance to disease may be discovered by appropriate statistical analysis in such a framework. To validate our methods, we will use data from the Wellcome Trust Case Control Consortium (WTCCC; we already gained access to data), The Database of Genotypes and Phenotypes (dbGaP; we are in the process of gaining access to data), and Candidate Gene Association Resource (CARe) project (we have access to data and have published preliminary results). Our results generated from these studies will be benchmarked by functional enrichment analysis and comparison to expert curated gene sets. In addition, we will utilize gene expression data from relevant tissues with appropriate phenotypes to assess the mRNA-level dysregulation of identified subnetworks. We will then investigate whether these variants can be used in combination to enhance assessment of risk for individuals through cross-classification studies. At each step of validation, we will compare the subnetworks identified by our algorithms to genetic markers identified by other available methods. In summary, the proposed computational algorithms will enable extraction of functionally relevant information from genome-wide association studies, identify complex associations that are not readily captured by standard association techniques, and potentially improve the predictive ability of association studies in linking genotype to phenotype for clinical and translational research.